Measuring Postpartum Pregnancy Risk to Improve Healthy Birth Intervals

Project Summary
Although the World Health Organization recommends using postpartum family planning (PPFP) to promote
healthy birth spacing to improve maternal and newborn outcomes, approximately 60% of postpartum women in
low- and middle- income countries (LMICs) do not use contraception. Understanding demographic and
temporal variation in the biological and behavioral determinants of postpartum pregnancy risk can help identify
or strengthen family planning interventions during a critical reproductive window, yet research on this topic has
been limited by data and methodological constraints. The goal of this research is to identify when women are
at risk of short birth intervals during the postpartum period and the dynamic behaviors that increase or reduce
such risk in Ethiopia. The proposed project will use two cohorts of longitudinal, population-based survey data
following pregnant and postpartum women for 12 months after birth, with a total sample of approximately 5,209
Ethiopian women to achieve two specific aims. First, we aim to establish common postpartum pregnancy
risk trajectories of women in a setting with low PPFP use and high risk for adverse maternal and
newborn outcomes associated with short birth intervals. Using monthly data in the 12-month postpartum
period on contraceptive use dynamics, sexual activity, and return of menses, we will use sequence and cluster
analyses to identify and understand risk profiles for short birth intervals. Second, we will identify individual,
interpersonal, and health system factors that predict postpartum pregnancy risk trajectories. We will
use multivariable logistic regression to determine if and how individual (e.g., sociodemographic); interpersonal
(e.g., intimate partner violence); and health system (e.g., PPFP counseling over the continuum of care) factors
are related to postpartum pregnancy risk trajectories. By identifying risk profiles of women as they relate to
short birth intervals, particularly women at sustained high risk for unintended pregnancies, the findings will
inform and better tailor ongoing efforts and interventions in Ethiopia by revealing potentially modifiable risk
factors. Results can also inform future research in similar LMIC contexts, as both a proof of concept for the
methodology’s applicability to the postpartum period, as well as related to the specific findings.

Public health relevance
PROJECT NARRATIVE Postpartum family planning (PPFP) is an effective intervention to promote healthy birth spacing and enhance maternal and newborn outcomes, yet many postpartum women do not use contraception because they perceive their risk of pregnancy as low. This project identifies when women are at risk of short birth intervals during the postpartum period and examines the behavioral, interpersonal, and health system factors that increase or reduce such risk. Findings from this project are critical for enhancing the quality of counseling services and aligns with the principles of person-centered contraceptive care and contraceptive autonomy, ensuring that women's contraceptive choices are better attuned to their individual needs and preferences.